National User Resource for Biological Accelerator Mass Spectrometry

PROJECT SUMMARY
The National User Resource for Biological Accelerator Mass Spectrometry (User Resource) provides ultra
sensitive isotopic analysis (primarily radiocarbon or Carbon-14) by accelerator mass spectrometry (AMS) for
NIH-funded and other researchers. It is the only User Resource of its type in the United States. The User
Resource leverages 20 years of expertise in the development and application of AMS in broad-based biomedical
research through the Biomedical Technology Research Resource for the Development of Biomedical Accelerator
Mass Spectrometry (BTRRAMS): a NIGMS Biomedical Technology Center (P41GM103483 09/01/2000 –
05/31/2020). Since June 2014, BTRRAMS and User Resource have measured approximately 4,000 samples a
year for its user community. The User Resource will continue to meet the needs of current users as well as
provide a capability for new users who would benefit from incorporating AMS as a measurement tool into their
research programs. The User Resource’s forte is ultra-high sensitivity quantitation of radiocarbon and selected
other radioisotopes for research studies where isotopes are required. Radioisotope labeling studies continue to
be an important tool for addressing many complex problems in the biomedical sciences. AMS is a specialized
and unique type of mass spectrometry that provides absolute quantitation of radiocarbon and other relevant
other isotopes with limits of detection in real samples on the order of a few attograms/mg sample. As a National
Resource, the most significant work enabled by AMS is likely to be quantitation of metabolic pathways in human
health states and comparison to ex vivo and in vivo animal models. The technology made available enables a
deeper understanding of the etiology of human health concerns by (1) enabling the ability to quantify
pharmacokinetics and other molecular endpoints directly in humans; (2) offering the ability to conduct quantitative
studies using biologics such as proteins or lipids; and (3) enabling more relevant studies of metabolic pathways
in health and disease through the use of much lower, more biologically-relevant, concentrations of metabolic
substrates in cells and intact organisms. Such studies support NIGMS’s basic biomedical research areas that
contribute to the understanding of fundamental cellular and physiological principles. The User Resource has
three goals: (1) provide high throughput, ultra-sensitive 14C analysis for the NIH user community; (2) improve the
efficiency of ultra-sensitive 14C analysis through installation of new interfaces to our AMS systems, improvements
in ion source efficiency and upgrades to our data analysis codes; and (3) increase the accessibility and visibility
of ultra-sensitive 14C measurements for the biomedical research community by training new investigators and
expanding the National user base of researchers requiring ultra-sensitive 14C analysis. The proposed purchase
of the Waters UHPLC system will replace the no longer supported, retired Agilent 1100/1200 system in our AMS
sample prep laboratory.

Public health relevance
Project Narrative The National User Resource for Biological Accelerator Mass Spectrometry (User Resource) provides ultra- sensitive Carbon-14 isotopic analysis by accelerator mass spectrometry (AMS) for NIH-funded researchers. The User Resource enables a deeper understanding of the etiology of human health concerns by enabling quantification of pharmacokinetics and other molecular endpoints directly in humans: offering the ability to conduct quantitative studies using biologics such as proteins or lipids; and enabling more relevant studies of metabolic pathways in health and disease through the use of much lower, more biologically relevant, concentrations of metabolic substrates in cells and intact organisms. The User Resource increases the accessibility and visibility of ultra-sensitive 14C measurements by training new investigators and expanding the National user base while concurrently improving the efficiency of AMS measurements through installation of new interfaces, technical modifications to ion sources and upgrades to data analysis software for improved ease of use and data reporting.